Enrichment Program

PROJECT SUMMARY Enrichment Program
The overarching objectives of the Enrichment Program of the WU DDRCC are to promote and encourage
scientific dialog and collaboration among Center members, to nurture and support training and career
development for trainees and junior faculty, including underrepresented minorities (URMs), in digestive
disease related research, to highlight new advances that promote interest in our thematic areas and to
stimulate interaction and collaborations with other NIDDK centers and DDRCCs. KEY
ACCOMPLISHMENTS: The Enrichment Program promotes the goals of the WU DDRCC through weekly
research conferences that attract a confluence of communities, including trainees and faculty in the Division of
Adult and Pediatric Gastroenterology, DDRCC members and a range of WUSM faculty with interests in digestive
disease and host-environment interactions. These weekly research conferences are widely advertised, well
attended (average 45 attendees) and function to promote interest in digestive disease throughout the WUSM
community. We collaborate with other WU NIDDK Centers (including Nutrition Obesity Research Center (NORC)
and Diabetes Research Center (DRC)) and across Departments (including Pediatrics, Pathology and
Immunology, Molecular Microbiology) to co-sponsor annual workshops highlighting important research themes.
The Enrichment Program also sponsors workshops devoted to career advancement and academic skills and to
promote collaborations between junior and senior faculty. In addition, the Enrichment Program sponsors an
alternate year poster presentation event in conjunction with our External Advisory Board visit to highlight all Pilot
and Feasibility (P/F) accomplishments. The Enrichment Program also sponsors mini-sabbaticals for up to one
month for trainees to visit other Centers (including DDRCCs). SPECIFIC AIMS for current cycle: (1) Coordinate
weekly seminar series focusing on digestive disease related themes, including internal and external speakers
as well as presentations from Core Directors. This includes maintaining an infrastructure for electronic/web
based dissemination of announcements and information. (2) Sponsor a panel of ~10 visiting researchers
annually (selected by Thematic Program Leaders) to augment the scientific milieu, promote collaboration and
stimulate development of new initiatives in digestive disease. (3) Sponsor one designated URM speaker per
year. (4) Support career development of trainees and junior faculty (including URMs) to pursue careers in
Digestive Disease (DD) research, through didactic talks and seminars focusing on academic skills as well as
through meetings with visiting speakers and with members of the External Advisory Board. (5) Coordinate
alternate year poster presentations of P/F Awardees to coincide with EAB meeting. (6) Sponsor mini-sabbatical
visits for junior faculty or trainees to acquire new skills related to DD research (7) Sponsor monthly thematically
related journal clubs/interest groups. (8) Support and promote dialog with other Midwest DDRCCs through an
annual meeting rotating among other centers, specifically promoting career development for P/F Awardees.